Genomic predictors of smoking and lung cancer risk

Abstract – Project 1
Lung cancer (LC) is the leading cause of cancer. Lung cancer is among the best examples of a disease resulting
from a complex interaction between environmental exposures and genetic factors. Germline genetic findings make
an important contribution to the definition of high-risk individuals and provide key insights into LC etiology. LC
genome wide association studies (GWAS) have identified informative loci that have influenced our approach to
tobacco control and provided new insights into tumorigenesis. We have identified 24 loci with involved in cancer
susceptibility. However, the interplay between inherited susceptibility and effects from demographic and
environmental factors has not been elucidated. We hypothesize that genetic variation influences both smoking
behaviors and cellular processes that jointly lead to lung cancer development. Our specific aims are: Aim 1
of this project will characterize the contribution of common genetic variation to lung cancer etiology. We
will analyze GWAS of lung cancer from 47,506 lung cancer cases and 63,687 to identify factors influencing lung
cancer risk according to histology and host-characteristics. Mechanisms by which these variants influence cancer
risk will be explored using eQTL based procedures and through annotation of existing databases. Aim 2 will
investigate uncommon genetic variants for LC susceptibility. We will analyze exome germline sequencing
information from over 2,500 lung cancer cases and 2,000 controls use these for imputation and rare variant
analysis. Aim 3 will identify genetic effects on smoking behavior. For this aim, we will integrate the large-scale
genetic studies we have conducted with extensive phenotyping performed through the lung cancer cohort
consortium (LC3) and project 2 to identify the specific impacts of SNPs on smoking behaviors. Aim 4 will
characterize joint effects of environmental and genetic interactions on lung cancer risk. This extensive data
and information from cohort studies we have assembled will allow us to model joint effects of smoking and genetic
factors on lung cancer risk over time. Supported by the biostatistical core we will perform mediation analyses to
partition risk among multiple smoking phenotypes and genetic factors. We will also use the genetic data to perform
Mendelian randomization to evaluate the relevance of biomarkers in predicting lung cancer risk, to assist project 2.

Public health relevance
Narrative – Project 1 Lung cancer is among the best examples of a disease resulting from a complex interaction between environmental exposures and genetic factors. This project will identify novel genetic variants contributing to lung cancer development and explore causes for these associations through expression quantitative trait locus analysis and analysis of rare variants. We will study the joint effects of smoking and genetic factors on lung cancer risk.